Skin-Intrinsic Immunosuppressive Mesenchymal Stem Cells and aGVHD

Project Summary/Abstract
Acute graft-versus-host disease (aGVHD) is a major limiting complication of allogeneic stem cell
transplantation for the treatment of leukemia/lymphoma and certain solid tumors. aGVHD occurs when T
lymphocytes from donor bone marrow attack cells within the recipient that are critical to the function vital
organs, namely skin, liver and gut. During the past three decades of research, Dr. Murphy’s laboratory has
found that in skin and squamous mucosae, the first sites of effector-target cell interaction provoked by
differences in minor histocompatibility antigens, involve T cells bearing Vb-specific markers that home
selectively to epithelial rete ridges as well as the epithelial stem cell-rich bulge regions of murine hair follicles.
This association results in death by apoptosis of adjacent epithelial cells that express the stem cell marker,
cytokeratin 15. Systemic therapeutic inhibition of these effector limbs is riddled with problems that include
collateral impact on immune reconstitution and blunting of graft-versus-tumor effects. However, we now know
through discoveries made in collaboration with co-PIs of this proposal, Drs. Markus and Natasha Frank, that
the skin and squamous mucosae harbor intrinsic cellular pathways capable of potent immunosuppression.
Specifically, we have discovered a dermal dendritic cell that has stem cell characteristics, expresses the
multidrug resistance transporter ABCB5, and also expresses PD-1. This cell has the ability to thwart T cell
responses, including alloreactivity, and therefore holds significant but as yet unexplored promise as a skin-
intrinsic pathway that may be leveraged to inhibit the tissue injury in aGVHD. In this proposal, Dr. Murphy and
the Drs. Frank have combined forces to address the long-term objective of harnessing the skin’s intrinsic
immunosuppressive capabilities to thwart aGVHD. The proposal’s specific objective is to determine the impact
of PD-1-expressing immunosuppressive dermal mesenchymal stem cells on the earliest and most specific
effector-target cell interactions responsible for aGVHD. To this end, we have proposed three specific aims:
1) to correlate spatiotemporal multiplex immune profiling with all aspects of disease morbidity and recovery
in aGVHD; 2) to dissect ABCB5 dermal stem cell function in aGVHD and define PD-1/PD-L1-centered
strategies for skin-intrinsic immunosuppression; and 3) to apply ABCB5+ dermal stem cell transplant
strategies to influence aGVHD severity using spatiotemporal multiplex immune profiling as effector-target
bioassay. The approaches involve state-of-the-art multiplex immunophenotyping of effector-target cell
interactions that sensitively and specifically typify tissue injury in aGVHD, and leverage ABCB5 gene knockout
and lineage tracing models in context of PD-L1 Ig administration and ABCB5+ stem cell engraftment. The
rationale is that upon successful completion of this work, we will identify novel therapeutic approaches to the
treatment and prevention of aGVHD skin and squamous mucosal pathology through manipulation of skin-
intrinsic immunosuppressive pathways.

Public health relevance
Project Narrative Although allogeneic bone marrow transplantation saves lives of patients with leukemia/lymphoma and certain solid cancers, this therapy is limited when transplanted bone marrow cells attack recipient organs, including skin, in the disorder termed acute graft-versus-host disease. This proposal focuses on how we can manipulate and enhance the skin’s own built-in system designed to suppress such life-threatening immune responses by focusing on a newly-discovered cell termed a dermal mesenchymal stem cell. If successful, we will develop new therapeutic approaches to harness the dermal mesenchymal stem cell to inhibit graft-versus-host disease, and potentially may other inflammatory conditions that affect skin and other vital organs.